OpenScope: A Platform for High-Throughput and Reproducible Neurophysiology Open to External Scientists to Test Impactful Theories of Brain Function

Project summary
Over the past five years, the Allen Institute has built two unique in-house pipelines for in vivo electro- and
optical-physiology: together they form the Allen Brain Observatory. We used this observatory to freely and
openly share calcium imaging data from ~60,000 cells from 221 running mice viewing standard visual stimuli;
in October 2019, we will release Neuropixels electrophysiology recordings from ~100,000 cells from 100 mice
under the same conditions, all registered to a common anatomical coordinate system (CCFv3). We wish to
open the Brain Observatory pipeline to the community, enabling theoretical, computational, and experimental
scientists to test sophisticated hypotheses on brain functions in a process analogous to astronomical
observatories that survey the night sky. Our observatory, called OpenScope, will accept, once a year,
experimental proposals from external scientists, which will be reviewed by a panel of leading experts for their
feasibility and scientific merit. The Allen Institute will carry out the selected experiments by following verified,
reproducible, and open protocols for in vivo single- and multi-area two photon calcium imaging and
Neuropixels electrophysiology, making the data freely available to these scientists. Funding for this proposal
will give the entire community access to a modern experimental platform that operates under standardized,
reproducible, and high-throughput conditions. This resource will be particularly attractive to the computational
and theoretical communities with limited access to experimental facilities. Our project has the potential to
transform systems neuroscience by implementing an observatory model that has been tremendously
successful in other scientific fields. By reducing variability in training, imaging and quality control across
animals and experiments and by lowering the barrier to select, test, and validate the best ideas, we hope to
accelerate progress toward an integrated view of neural circuits.

Public health relevance
Project narrative Scientific fields such as astronomy and particle physics have had tremendous success using an “observatory” based approach to data collection, in which researchers propose experiments to be carried out in centralized facilities too complex and expensive to be operated by individual laboratories. We will apply this model to neuroscience by opening the Allen Institute Brain Observatory’s state-of-the-art optical and electrophysiological data collection pipelines to the entire neuroscience community. This will lower barriers to testing new hypotheses about brain function, bring in new computational and theoretical talents into the field, and enhance the reproducibility of results in brain research, thereby accelerating progress toward an integrated understanding of neural activity in health and disease.